Multivariate Decoding of the Retrieval Brain State Across Cognition

Brain states – stable patterns of whole-brain activity and connectivity – dictate neural processing and behav-
ioral outcomes, yet understanding of speciﬁc brain states remains limited. In particular, there has been limited
consideration of how the retrieval state may drive the processes and representations that support memory and
cognition. The long-term goal of this research program is to link cognitive brain states and behavior. The overall
objective of the current application is to deﬁne the properties of the retrieval state. The central hypothesis of this
proposal is that the retrieval state reﬂects a control-independent internal attention brain state. The speciﬁc aims
of this proposal are to establish retrieval state temporal dynamics, link retrieval and internally directed attention,
and identify the factors that induce retrieval. This proposal will use multivariate decoding of scalp EEG data to
index trial-level retrieval over time and across tasks. The ﬁndings of the current proposal are expected to provide
a signiﬁcant conceptual advance that will be broadly relevant to understanding memory and cognition.

Public health relevance
This proposal will establish the extent to which retrieval constitutes a control-independent internal attention state. The results are expected to advance understanding of how the retrieval state may drive the processes and representations that support memory and cognition. In so doing, this proposal will provide a foundation for under- standing and identifying memory performance deﬁcits across the lifespan in healthy individuals and in patients suffering from cognitive impairments due to stroke or disease.